CLINCIAL VALIDATION OF APC AND TP53 AS BIOMARKERS FOR CETUXIMAB RESPONSE

PROJECT SUMMARY/ABSTRACT
The objective of this combined UH2/UH3 application is to develop a cost-effective, rapid, test that can be
rapidly translated to the clinic and ultimately be used to re-purpose a class of FDA-approved colorectal
cancer (CRC) EGFR inhibitor (EGFRi) therapeutics (cetuximab and panitumumab). To date, only negative
genetic predictors (mutant KRAS/NRAS) of EGFRi response have been employed clinically, currently
restricting EGFRi use to wild-type RAS/RAF subpopulations, and more recently, just to “left-sided” lesions.
We recently reported a new prognostic role for APC that relates to the number of alleles mutated and to the
association with other mutant genes such as KRAS and TP53 (Nat Commun, 2016). Further analysis also
revealed that mutant APC (A) genotypes, in combination with mutant TP53 (P), are strongly correlated with a
gene expression signature measuring cetuximab sensitivity (CTX-S). These data led to the provocative
hypothesis that mutant APC + TP53 (AP) genotypes together---more so than either mutant gene alone (A_ /
_P), or wild-type AP (_ _)---may have a new role in positively-predicting EGFRi outcomes (Nat Commun,
Under Review, 2018). This hypothesis is based on 3 key observations we have recently made in our cohort
and in TCGA data:
(1) CTX-S scores are significantly higher in: AP > A_ / _P > _ _ tumors in both WT and MUT KRAS tumors;
(2) AP mutations are more frequent in Left (cetuximab-sensitive) > Right (cetuximab-resistant) CRC;
(3) AP mutations are almost non-existent in MSI tumors (highly cetuximab-resistant).
These findings have two potentially high-impact clinical implications: (1) they re-define the patient selection
strategy by further restricting EGFRi therapies to wild-type RAS/RAF patients harboring AP mutations, thereby
increasing response rates; (2) they could expand the therapeutic opportunity to treat a substantial number of
previously-excluded mutant KRAS/NRAS patients who have AP mutations in both left and right CRCs. If the
test for these mutations is developed and clinically validated, the utilization of these drugs could be expanded
to ~25% more patients, including more first-line patients. For the vast majority of CRC patients, AP
mutations are not assessed in current practice. Unlike KRAS/NRAS oncogenes, both A and P are tumor
suppressor genes that can have a multitude of inactivating mutations that must be detected. Thus, there is an
opportunity to change clinical practice and standards of care to ultimately improve CRC outcomes with a new
test.
In the LabCorp CAP/CLIA environment, we plan to develop a new highly sensitive, specific and cost-effective
targeted DNA-sequencing “assay” to detect mutations in the coding regions of the principal genes APC, TP53,
KRAS, BRAF, NRAS from formalin fixed paraffin embedded (FFPE) tissue samples.
In the UH2 Phase of this proposal, a new FFPE targeted DNA sequencing assay, with greater potential to
accurately detect mutations at low allelic frequencies, will be analytically validated with the following
approaches so that it can be offered in a CAP/CLIA laboratory for testing clinical samples:
(1) A variety of cell lines, both native and engineered, will be used to ensure analytic sensitivity, specificity, and
reproducibility.
(2) ~100 formalin fixed paraffin embedded (FFPE) samples of variable age, quality, tumor heterogeneity,
grade, and stage matched to the highest quality, “gold standard” fresh frozen (FF) samples from the same
originating tumor will be used to assess assay performance.
In the UH3 Phase, we plan to perform clinical validation of the test developed in the UH2 Phase to provide
evidence that the presence of AP mutations may predict EGFRi responses translating into improved clinical
outcomes. Here, we will demonstrate that assay of APC and TP53 genotypes along with those already
performed as SOC (KRAS/NRAS/BRAF) can be clinically validated (i.e. used to predict cetuximab
sensitivity/response) using human samples derived from:
(1) a retrospective CRC observational study relating CRC genetics to predicted cetuximab sensitivity.
(2) a historical NCI trial (CALGB 80203) where patients were treated with cetuximab but were not sequenced.

Public health relevance
PROJECT NARRARTIVE The epidermal growth factor receptor (EGFR) is a major therapeutic target in metastatic colorectal cancer (CRC). Currently, only negative predictors (mutant KRAS/NRAS/BRAF) of EGFR inhibitor (EGFRi) response have been employed clinically, restricting EGFRi use to wild-type RAS/RAF subpopulations. We recently developed the hypothesis, supported by extensive preliminary data, that mutations in APC and TP53 may positively select patients likely to respond to EGFRi therapies. This combined UH2/UH3 application is to develop a cost-effective, rapid, DNA-Seq test that detects APC and TP53 mutations and can ultimately be used to expand the treatment indications for FDA approved EGFRi therapeutics, cetuximab and panitumumab.